PATHOGENESIS OF DISEASE INDUCED BY FRIEND MULV

F-MuLV can induce several different hematopoietic neoplasms including T-+ B-Cell lymphoma, erythroleukemia and myeloid leukemia. As one approach to studying disease pathogenesis in this system, we cloned sites of F-MuLV provirus insertion in host DNA in an F-MuLV-induced myeloid leukemia. One 2.5 kb region identified in this manner was found to contain an F-MuLV provirus in one other myeloid leukemia and three thymic lymphomas out of a total of 90 tumors examined. This result indicated that proviral insertion sites in F-MuLV-induced tumors in host DNA are not random. It is likely that provirus insertions in this common integration region, designated Fis-1, confers a growth advantage. We mapped the Fis-1 locus to mouse chromosome 7, about 26 cM distal to the locus for beta globin. Surprisingly, we found that Fis-1 mapped to the same position as Int-2, a putative oncogene involved in murine mammary carcinomas. Nevertheless, Fis-1 and Int-2 are distinct since 30 kb of DNA surrounding Fis-1 do not overlap 30 kb surrounding Int-2, and proviral insertions in Fis-1 do not induce Int-2 mRNA. This Fis-1/Int-2 region may be involved in human B cell neoplasm since the human homologue of Int-2 has been mapped to the same chromosomal band as a locus involved in human B cell lymphoma, Bcl-1. Taken together, these observations identify a chromosomal region involved in the pathogenesis of a wide variety of malignancies in mouse and man. We are currently extending the region of cloned DNA surrounding Fis-1 in the hopes of finding an oncogene(s) which is activated by F-MuLV insertion and highly conserved between mouse and man.